NICHD Neonatal Research Network Clinical Center UAB

Project Summary
This application provides evidence that the clinical center at the University of Alabama at
Birmingham (UAB) meets and exceeds all the requirements of the NICHD Cooperative Multicenter
Neonatal Research Network (NRN) Request for Applications. The UAB clinical center, one of the
original seven clinical centers of the NRN, is a large perinatal center that includes a Level IV
neonatal intensive care unit (the only one in the State of Alabama) with 1607 admissions in
2020 and 1856 admissions in 2021, including 14% outborn infants.
The UAB clinical center has major strengths: (1) The UAB clinical center consistently has high
patient enrollment in NRN trials and studies, with highest enrollment in three of the current 13
studies including major randomized controlled trials (Cycled Phototherapy, MoCHA, and BiB),
second in Generic Database, and third in Follow-Up enrollment. UAB was also the top enroller
in the DARBE trial that is now closed to enrollment, (2) The UAB PI and the Alternate PI are
leaders in the NRN in development and leadership of two of the ongoing randomized controlled
trials (MoCHA and BiB), senior authors of eight peer-reviewed publications in the current NRN
cycle, and collegial committee members who foster rigorous research and collaboration, (3) The
Division of Neonatology members are committed to the NRN with six investigators at UAB having
been first authors of peer-reviewed NRN manuscripts published during the current cycle, (4) There
are strong clinical ties and integrated collaborative clinical research between the UAB NRN Center
and the UAB Maternal-Fetal Medicine Unit Network Center that foster an environment conductive
to excellence in perinatal trials, (5) The UAB Center has a well-established referral pattern that
includes all NICUs in the state and the statewide perinatal health care system, which assures a
large pool of high-risk admissions for clinical research in the coming years, and (6) There is a
comprehensive multidisciplinary follow-up program that assures excellent long-term evaluation and
care. This application highlights the strengths and commitment of UAB Clinical Center team to
continue participation in the NICHD NRN.

Public health relevance
Project Narrative UAB is one of the top performing sites of the Neonatal Research Network, leading in enrollment and in the design of innovative and seminal clinical studies. UAB’s participation in rigorously designed studies will identify strategies to reduce mortality and morbidity in neonates and provide evidence to guide neonatal care.